Admin Core-Maryland Population Research Center

Project Summary
The MPRC Administrative Core has as its goal the provision of services to allow the Center and its Cores to
operate as a smooth-running, productive, dynamic, and innovative unit that reaches across the university and
to the broader community of population research beyond. The Admin Core provides leadership and strategy for
the Center through the Center Director, Associate Director, and Executive Committee faculty roles. This
includes advocate for the MPRC within the university, and acting as liaison to university administration across
its departments, colleges, and schools. The Administrative Core Coordinator, as a full-time staff member,
serves a similar function at the level of the unit administrators across our Faculty Associates academic
departments. Everyday functions such as Associate and Affiliate membership application and tracking are
performed by the Admin Core. Services provided by the Admin Core to the MPRC Executive Committee
including meeting preparation and follow-up, and maintaining and retrieving as needed the “institutional
memory” of the MPRC. The Admin Core provides logistical and administrative support to researchers for vital
functions including external grant submission and management, and for research oversight, compliance, and
for research dissemination. The Admin Core provides the administrative services to maintain a moving target
of 80 to 90 Faculty Associates, plus those Associates’ sponsored internal and external MPRC research
affiliates, graduate student affiliates, and resident and visiting scholar UMD paid or unpaid employee
appointments. These additional, affiliate researchers play vital roles in increasing the research productivity,
innovation, and outreach of our Associates. The Admin Core’s information services to the Associates include
MPRC Working Papers, assistance with writing research press releases, preparation of weekly or bi-weekly
electronic circulars of population research news to Associates and Affiliates, and semi-annual Newsletters
advertising recent and upcoming MPRC activities to a wider audience. The Admin Core provides support to the
Scientific and Technical Core and the Development Cores. It provides highly efficient administrative staffing
services to those Cores, including for the handling of seed grant applications, collaborative and workshop
space reservation, the tracking of Associates’ and Affiliates’ participation in MPRC activities, and enables them
access to both MPRC physical facilities and to university privileges ranging from electronic and library
borrowing card provision to payroll system engagement. The physical facilities overseen by the Admin Core
include state-of-the-art meeting, conference rooms, collaborative spaces, restricted data laboratories, and
offices of MPRC staff and faculty directors, resident and visiting population scientists, and student affiliates and
research assistants. The Admin Core also provides support services that are vital for the logistics of
conferences and symposia organized by MPRC and held in both MPRC and other campus facilities.